Texas Pediatric NCORP

PROJECT SUMMARY
The Texas Pediatric MU NCORP is a consortium of five independent COG institutions serving South, West, and Central
Texas, including the Upper Rio Grande. Its catchment area spans 113 counties and over 140,000 square miles,
encompassing the entire Texas-Mexico border and parts of the New Mexico-Texas border. Population density varies
widely—from 15.4 to 122.6 people per square mile—reflecting both rural and urban communities, with many patients
facing long travel distances to access care. Border regions experience higher poverty, lower insurance coverage, limited
English proficiency, and lower high school graduation rates compared to non-border areas. These wide population
variabilities significantly impact the consistency in delivering complex cancer treatments.
The overarching goals of the Texas Pediatric MU NCORP therefore are to:
1.0 Improve the outcome, both quantitative and qualitative, of children, adolescents and young adults (AYAs)
diagnosed with cancer through enrollment on clinical trials (therapeutic, cancer control and biology) closer to
home. This includes: 1) Promoting enrollment of pediatric cancer patients on increasingly complex clinical trials; 2) Increasing
participation of AYAs in the NCTN and NCORP clinical trials through targeted activities; and 3) Supporting the
participation of Spanish-speaking patients and families by providing culturally sensitive Spanish-translated study-
related materials.
2.0 Consolidate the Texas Pediatric MU NCORP’s involvement in the Cancer Care Delivery Research (CCDR) arena by:
1) Proposing new COG and cross-network CCDR studies in the arena of genetic counseling, health literacy
pertaining to innovative treatment modalities and other proposals addressing cancer care delivery to Non-English
speaking and/or medically underserved participants; 2) On-going participation in study committees and COG CCDR
leadership; and 3) Leveraging the NCTN to maintain a cross-network portfolio of active studies that meet our
population’s needs.
3.0 Maintain and retain a cadre of trained Clinical Research Associates (CRAs) to support participation of children and
AYAs with cancer in the increasingly complex NCTN and NCORP clinical trials portfolio. This will involve promoting,
supporting and engaging CRAs in the research base committees (COG and others) and collaborative projects with
other NCORP institutions.

Public health relevance
PROJECT NARRATIVE This project aims at improving the outcome of children, adolescents and young adults with cancer through enrollment on cancer clinical trials, implementa9on of cancer care delivery studies targe9ng systems/providers modiﬁable factors and maintain a cadre of qualiﬁed research personnel to ensure data integrity.